K.C. Donnelly Externship - Promotion of Translational/Transdisciplinary Efforts in Graduate and Post-Doctoral Research

Project Description-(Abstract)
Per-and polyfluoroalkyl substances (PFAS) are a serious concern due to extensive contamination in environment. As
compared with other contaminants, PFAS are persistent, bioaccumulative and resistant to degradation. Therefore, effective
clean-up of PFAS is urgently needed. Using plants to extract PFAS from soils through phytoremediation may be a practical
approach. Our previous studies have investigated uptake of PFAS by hemp plants from soil, but this strategy is mostly
limited to the removal of short-chain fluorinated molecules. Our existing R01 project investigates phytoremediation
enhancement with novel materials such as ultra-mesoporous silica nanoparticles (UMNs) and carbon dots (CDs). Tuning
the surface chemistry of these nanomaterials will enhance uptake of PFAS by plants and luminescent carbon dots will
enable real time tracking of these materials in plants. Still, the disposal of PFAS contaminated biomass remains a challenge.
Biodegradation of PFAS by microbes is a promising technology. It is a sustainable, green process that requires low capital
and maintenance costs. Our preliminary studies achieved >70% degradation of perfluorooctanoic acid (PFOA) from PFAS
contaminated hemp biomass following a reductive defluorination method using A6 microbes. Here, we propose to further
investigate the microbial degradation of PFAS in contaminated hemp plants via a reductive defluorination method using a
novel Acidimicrobiaceae sp. strain A6 and to assess the effect of nanomaterials on the PFAS degradation.
1

Public health relevance
NARRATIVE Per- and polyfluoroalkyl substances (PFAS) are widespread, environmentally persistent, highly toxic, contaminants of emerging concern. Phytoremediation is a promising approach for PFAS removal; however, it is not effective for all classes of PFAS. Still, disposal of PFAS contaminated plant biomass remains a challenge. Therefore, we are investigating the microbial degradation of PFAS in contaminated plant biomass via a reductive defluorination method using a novel Acidimicrobiaceae sp. strain A6 and to assess the effect of nanomaterials on the PFAS degradation.